Schwann Cell Reprogramming and Cancer Perineural Invasion

The ability of some cancers to invade in, around, and along nerves is a process termed perineural invasion (PNI). PNI is an indicator of aggressive disease that is associated with morbidity from nerve dysfunction, increased recurrence, and worse survival. Cancer cells (CC) may be stimulated by a variety of neurotrophic factors released by nerves to facilitate PNI. This finding highlights the participatory role of the nerve microenvironment in enabling this adverse process. Schwann cells (SC) are key mediators of PNI; they intercalate between CC, facilitate CC dispersion, recruit CC to nerves, enhance CC invasion, and ultimately promote PNI. Interestingly, SC activity in PNI recapitulates the normal SC response following nerve injury. After nerve trauma, quiescent, myelinating SC are reprogrammed to an active subtype that shares characteristics with progenitor, dedifferentiated, stem-like SC. These “repair” SC release neurotrophic factors, recruit macrophages, and promote nerve repair. SC reprogramming following nerve injury may be controlled by c-Jun or Raf-ERK signaling. We hypothesize that the SC supporting nerves undergoing cancer invasion experience a transition similar to SC response following nerve injury. SC affected by cancer invasion are reprogrammed to acquire a phenotype that enables PNI. This SC phenotype includes: a transformation to a dynamic and motile cell able to interact with other cell types, the release of neurotrophic ligands, the expression of new cell adhesion molecules, and the ability to recruit macrophages to sites of PNI. Each of these acquired capabilities recapitulates similar SC reprogramming as a normal response to trauma, but may paradoxically promote PNI. We will explore how the interactions between SC and cancer are derived from a conserved nerve-repair program that is exploited by various cancers to facilitate their progression. This cross-disciplinary proposal combines expertise from oncology, neurodevelopment, cell biology, macrophage trafficking, pathology, and biostatistics to: 1. Characterize SC reprogramming in PNI and elucidate the drivers of this process. We will explore parallels in SC plasticity between nerve injury and PNI. 2. Determine how reprogrammed SC directly promote PNI. We will determine how SC c-Jun and Raf-ERK signaling impact PNI, and assess how reprogrammed SC mechanistically support PNI. 3. Assess how reprogrammed SC recruit inflammatory monocytes to indirectly promote PNI. We will determine mechanisms of SC-mediated monocyte recruitment and define how macrophages promote PNI. Our overall objective is to elucidate the relationships between cancer PNI and SC nerve-repair mechanisms to identify novel targets for therapy. Understanding how normal nerve response to injury paradoxically supports cancer invasion may reveal novel opportunities and strategies to interrupt this highly adverse process.

Public health relevance
Perineural invasion is an ominous form of cancer invasion where cancer cells track along nerves, making these cancers difficult to eradicate. Schwann cells, which wrap around nerves and facilitate their conduction, play an active role in promoting nerve repair and perineural invasion. This proposal will explore how the Schwann cell repair program is exploited by cancer cells to paradoxically promote perineural invasion.